Core E: Outreach, Recruitment, and Engagement Core

ABSTRACT – OUTREACH, RECRUITMENT, AND ENGAGEMENT CORE
The overall goal of the proposed Outreach, Recruitment, and Engagement Core is to cultivate the inclusive and
active participation of diverse persons underrepresented and understudied in research on the etiology,
pathogenesis, diagnosis, treatment, and prevention of Alzheimer’s disease and Alzheimer’s disease-related
dementias (AD/ADRD). Active participation is achieved by providing educational services created and tailored
to meet the expressed needs of diverse persons underrepresented and understudied in aging research.
Continuing a long tradition of applying an integrated program to promote diverse inclusion in the proposed
Rush Alzheimer’s Disease Research Center (ADRC) and other National Institute on Aging (NIA) research
initiatives, the Specific Aims of the proposed Outreach, Recruitment, and Engagement Core are to: 1) network
with leaders in communities underrepresented and understudied in aging research to cultivate mutually
respectful and mutually beneficial relationships; (2) give first to communities underrepresented and
understudied in aging research by meeting their expressed needs for education, resources, and support
services regarding age-related cognitive conditions including normal aging, mild cognitive impairment (MCI),
and AD/ADRD; (3) advocate for research participation in Rush ADRC and NIA research initiatives to address
unanswered community needs; (4) give back to communities underrepresented and understudied in aging
research by disseminating information about Rush ADRC and related NIA research findings to build community
capacity to better serve diverse persons living with cognitive conditions and their caregivers; (5) evaluate the
effectiveness of Outreach, Recruitment, and Engagement Core activities to strengthen capabilities to engage
with communities underrepresented and understudied in aging research; and 6) design and develop research
conducted by the Rush ADRC and other NIA research initiatives that integrate diverse participant perspectives
to facilitate the transfer of information between diverse older adults and researchers to enhance the impact of
such research initiatives. The Outreach, Recruitment, and Engagement Core will collaborate with other Rush
ADRC Cores to achieve its Specific Aims including Clinical Core (Aims 3, 4, and 6), Data Management and
Statistical Core (Aims 3 and 5), Latino Core (Aims 3, 4, and 6), and Religious Orders Study Core (Aims 3, 4,
and 6). By leveraging enduring relationships in diverse communities and integrating diverse participant
perspectives, the Outreach, Recruitment, and Engagement Core will facilitate active participation by persons
underrepresented and understudied in research on the etiology, pathogenesis, diagnosis, treatment, and
prevention of AD/ADRD.